Signal sensing, hyphal development and pathogenesis of Candida albicans

PROJECT SUMMARY/ABSTRACT
Parent Grant: R01GM117111-06
No changes are proposed to the Project Summary/Abstract by the proposed supplement activities.

Public health relevance
PROJECT NARRATIVE Parent Grant: R01GM117111-06 No changes are proposed to the Project Narrative by the proposed supplement activities.